Chemical Pattern Detection and Visualization in Biological Networks

DESCRIPTION (provided by applicant): While the massive amount of molecular bioactivity data creates new opportunities, it also hinders the way scientists conduct biomedical research due to the inherent difficulty of processing many separate and heterogeneous data sources. The quality and type of data input often limits the project outcome. To improve research outcome, access to all available data and multiple alternative hypothesis testing are essential. Targeting less experienced end-users, we will develop tools that facilitate "jumps" in the small molecule / bioactivity / biomedical data area, leading from one potential solution to another, encouraging users to explore multiple, alternate hypotheses. We will integrate data from multiple bioactivity databases, including PubChem, ChemBank, ChEMBL, PDSP and WOMBAT, into one centralized system. We will develop advanced chemical pattern recognition algorithms and deliver a Cytoscape-based visualization tool for the global exploration of relationships between chemical patterns and biological activities/targets. We will achieve this via three Specific Aims: 1. Create one simple unified interface for many heterogeneous databases, CARLSBAD (Confederated Annotated Research Libraries of Small molecule Biological Activity Data);the data will reconcile small molecule bioactivity data across multiple sources for human, rat and mouse targets. 2. Develop advanced algorithms for chemical pattern detection and annotation;we will detect the Maximum Overlapping Set (MOS) and HierS (hierarchical scaffolds) and annotate chemicals in CARSLBAD accordingly. 3. Develop a Cytoscape plugin for the visualization and exploration of chemical pattern bioactivity networks. Via MOS/HierS patterns, users will be able to identify target specific chemical signatures (determinants for activity and selectivity);in the absence of specific signals, these patterns will serve as rationale for off- target and promiscuous bioactivity prediction. Storing unique target-ligand bioactivity data as well as chemical patterns, CARLSBAD will be designed, implemented and maintained on an enterprise platform for use by the scientific community. The new Cytoscape plugin will integrate with existing core components and plugins to bridge across chemistry and biology in a multi-disciplinary manner. PUBLIC HEALTH RELEVANCE: The proposed research aims to empower the chemistry and biology research community with an innovative, network-based tool for mining vast amounts of chemical and biological data. It will provide an effective and improved way for researchers to evaluate, visualize and explore small molecule bioactivity data in a multi-disciplinary manner, thus leading to improved output in human health research.

Public health relevance
The proposed research aims to empower the chemistry and biology research community with an innovative, network-based tool for mining vast amounts of chemical and biological data. It will provide an effective and improved way for researchers to evaluate, visualize and explore small molecule bioactivity data in a multi-disciplinary manner, thus leading to improved output in human health research.